Circadian Clock Disruption as a Novel Mechanism to Influence Osteoarthritis Risk in Aging Populations

PROJECT SUMMARY/ABSTRACT
Half of US adults age 65 or older report doctor-diagnosed arthritis, with osteoarthritis being the most common
type. While osteoarthritis is strongly associated with aging, the mechanisms through which the aging process
influences osteoarthritis risk and progression are still being explored. Circadian rhythm disruptions could be a
key component. Laboratory studies indicate that circadian rhythms are important factors for maintaining
homeostasis of the joint tissues. And genetic and environmental disruption of the circadian clock can lead to
osteoarthritis -like cartilage degeneration in rodent models. Circadian clock disruptions also increase risk of
obesity, a key osteoarthritis risk factor. But little is known about the relationship between circadian clock
disruption and osteoarthritis risk in human populations. Shift work, particularly night shift work, is an extreme,
but common example of such a disruption in the real-world. To better understand the links between shift work,
circadian clock disruption, and osteoarthritis, our goal is to evaluate the effect of duration of time in night shift
work and age at night shift work on osteoarthritis risk (Aim 1) and examine the influence of chronotype on
these associations (Aim 2). We will use the UK Biobank, a prospective cohort of half a million people in the
United Kingdom with data on genotype, shift work, and other relevant factors for osteoarthritis risk such as age,
sex, heavy manual labor, socioeconomic status, and body mass index. Frequency of night shift work is
reported by all working UK Biobank participants. Through the National Health Service, the full cohort is linked
to hospital data and half the cohort is linked to primary care data, providing reliable means to ascertain
osteoarthritis diagnoses and joint arthroplasty. Our team has extensive experience with UK Biobank, with
particular expertise examining occupational and genetic risk factors for musculoskeletal disease. Aim 1 will
focus on a 100,000-person subset of UK Biobank that reported lifetime job histories, including history of shift
work. Associations of years duration of night shift work and night shift work done at different ages will be
estimated with osteoarthritis endpoints. For Aim 2, associations of shift work with osteoarthritis endpoints will
be estimated in analyses stratified by chronotype, considering both self-reported chronotype and genetic
chronotype. Evaluation of the effect of duration of night shift work, age at night shift work, and the modification
of effects by chronotype will be a critical step forward in determining if these associations are indicative of the
effects of circadian rhythm disruption on osteoarthritis and identifying populations that may be most vulnerable.
Circadian clock disruption may be a novel risk factor for osteoarthritis that influences cartilage degeneration
both through effects on obesity, and obesity-independent pathways. These disruptions could be a crucial piece
of the relationship between aging and osteoarthritis. Importantly, as lifestyle changes and chronotherapy can
reduce circadian clock disruptions, these findings can point to new potential ways to prevent osteoarthritis
development and progression.

Public health relevance
PROJECT NARRATIVE Circadian clock disruption may be one mechanism through which aging influences osteoarthritis, and could be a novel, modifiable risk factor for osteoarthritis. To better understand the links between night shift work, a common form of circadian clock disruption, and osteoarthritis this proposal aims to evaluate the effect of duration of night shift work and age at night shift work on osteoarthritis risk and examine the influence of chronotype on these associations. Results from these aims will provide a critical step forward in determining if night shift work associations with osteoarthritis are indicative of the effects of circadian clock disruption and identifying populations that may be most vulnerable to these effects.